Sex differences in the role of multi-omicsin HIV-associated carotid artery atherosclerosis

MACS/WIHS Combined Cohort Study (MWCCS) Administrative Supplement:
Abstract. While significant recent changes in the clinical care of people with HIV (PWH) (e.g.,
universal ART initiation, greater use of statins as prophylaxis) have reduced cardiovascular
disease (CVD) risk, concurrent developments that may increase CVD risk (e.g., shift to
integrase inhibitors as first-line HIV treatment, continued aging of the HIV population) mean that
the determinants of CVD in PWH are ever-changing. We have the opportunity to extend our
existing MWCCS database of -omics measures in women in relation to HIV-associated CVD to
men, and expand the scope with additional assessments of the microbiome, metabolome, and
sex hormones. We propose to use archived specimens to measure gut microbiota and selected
microbiome-related metabolites and immune marker panels, including markers of immune
activation, gut barrier dysfunction and microbial translocation in relation to carotid
atherosclerosis in MWCCS men, and assess both the independent and mediating roles of sex
hormones in this relationship among both women and men with HIV. Our aims support
HIV/AIDS research that falls under the following NIH high priority AIDS-designated topics: 1)
immune dysfunction, persistent inflammation, and microbiome and genetic determinants that
underpin the development of high priority HIV co-morbidities, and 2) long-term treatment or
prevention strategies for HIV-relevant comorbid conditions across the lifespan.

Public health relevance
PROJECT NARRATIVE Our supplement will expand our MWCCS Data Center capacity to support two new supplemental aims being led by the Bronx team. This study will identify novel risk factors for atherosclerosis in men with and without HIV infection, focusing on gut microbiome and related factors and examine sex differences with findings previously identified in women.